PHASE 2 STUDY OF HU23F2G IN ACUTE EXACERBATIONS OF MULTIPLE SCLEROSIS

The in vitro biologic activity and in vivo efficacy of Hu23F2g in a nonhuman primate model of Experimental Allergic Encephamyelitis (EAE) support a potential application in the treatment of MS. The acute exacerbation component of MS will be studied under this protocol. The rationale is that the EAE model is associated with acute onset of neurologic deficits and new lesions in the CNS, events that are analogous to the actue MS exacerbation.